Carolina Center for Population Aging and Health

SUMMARY
We propose the Carolina Center for Population Aging and Health (CCPAH), which will provide
resources and organization to support a productive group of scholars as they increase the pace
and focus of their research on topics related to the demography and economics of aging. The
potential for CCPAH to make important contributions to aging research lies in the combination of
people, their analytical skills and ability to combine different sources of data in innovative ways,
and the array of data sets with information on mid-life and older individuals that have been
designed and collected by faculty associated with the proposed center. Our faculty have
developed and fielded a number of long-running population-based longitudinal surveys that
provide rich data for analysis of questions related to aging across a wide array of diverse
settings. CCPAH will provide important resources to the field of aging research by continuing to
innovate on measurement in these surveys and in new ones and on linkage of these surveys to
other administrative and contextual data, ensuring that the content of these surveys is state-of-
the-art. Resources from a P30 will support three Cores. An Administrative and Research Core
will create an environment that fosters collaboration and provides faculty with administrative and
research support so that they can focus on the science. A Project Development Pilot Core will
support pilot projects and assist with the development of proposals to NIH. A Remote Data
Enclave Core will build infrastructure to provide access to data in a secure but convenient way.
In combination these three cores will help CCPAH faculty produce cutting edge research in the
areas of our themes: aging in diverse contexts, relationships between economic and social
productivity and health, and measurement and methods. Each core supports each of the
themes. Over the course of the grant CCPAH faculty will design primary data collection efforts,
continue and begin new analyses of secondary data, as well as data they have collected, and
oversee the production and dissemination of data products through a P30-supported Remote
Data Enclave. These public goods will enrich the data to which researchers around the world
have access to advance science on aging.

Public health relevance
Public Health Relevance The Carolina Center for Population Aging and Health will support a productive group of scholars as they increase the pace and focus of their research on topics related to the demography and economics of aging. Faculty will conduct research and primary data collection in support of three themes: aging in diverse contexts, links between social and economic productivity and health, and measurement and methods. Research produced as part of this center will provide important new results on patterns and determinants of healthy aging around the world.